A Family-Genetic Study of Language in Autism

Project Summary
Pragmatic (i.e., social) language deficits are a defining feature of autism spectrum disorder (ASD), which can
impose significant burden on individuals throughout the lifespan. Strong evidence also suggests that this clinical
domain is influenced by genetic liability to ASD in unaffected relatives, constituting a principal component of the
broad autism phenotype (BAP) and linked with increased polygenic risk for ASD in unaffected relatives.
Pragmatic language features of ASD also show significant overlap with phenotypes observed in carriers of FMR1
mutations, implicating this highly penetrant ASD risk gene in the pragmatic language phenotype of ASD in
particular. The pragmatic language domain is therefore not only highly clinically significant in ASD, but also
sensitive to underlying ASD genetic liability, making this skill an important target for understanding the biological
origins of ASD and its component features, with potentially important clinical applications. In this competing
renewal, we will apply innovative deep phenotyping methods and an armamentarium of complementary analytic
platforms to dissect the contributors to pragmatic language impairments in ASD and their biological basis. Using
a family-study design and including a representative ASD cohort enriched for girls, ASD parents, and respective
control groups, we will characterize ASD-related pragmatic profiles that extend beyond traditional, categorically-
defined diagnostic boundaries, which may be linked with distinct neural signatures and molecular genetic
variation. Aim 1 will apply both hypothesis- and data-driven analytic approaches to analyze a comprehensive
battery assessing component skills contributing to pragmatic impairments in ASD, and subclinical pragmatic
differences in the BAP among parents. Aim 2 will employ a battery of targeted electrophysiological measures to
examine potential neural correlates of pragmatic impairment in ASD and the BAP. Finally, Aim 3 will evaluate
the relationship between behavioral and neural phenotypic signatures obtained in Aims 1 and 2, respectively,
and FMR1-related genetic variation. Our preliminary studies demonstrated a complex network of skills
contributing to pragmatic impairments in ASD that may be sensitively measured with the advanced fine-grained
computational- and machine-learning-based approaches proposed in this project, with compelling ties to
neurophysiological and molecular genetic correlates that will be measured in this project. Together, the rich and
extensive data produced will contribute to the understanding of the fine-grained skills that contribute to the
heterogeneity in ASD, and the mechanistic and biological origins of this important clinical domain. Our findings
will move us closer to achieving our long-term translational goal: to advance our understanding of the causes of
the pragmatic language impairment in ASD in order to improve prediction of clinical outcomes and help guide
future interventions and treatment in ASD.

Public health relevance
Project Narrative The proposed competing renewal is a multi-site, interdisciplinary project bringing together basic, translational, computational, and clinical investigators to support critical research on pragmatics, the social language skills that are most profoundly impaired in autism spectrum disorder (ASD). Using a family study design, we examine pragmatic language profiles that extend beyond traditional diagnostic boundaries and may be linked with neural correlates and specific molecular genetic variation, studying a cohort enriched for girls, who have been historically underrepresented in studies of pragmatics in ASD. Study aims will generate findings, resources, and tools that will lead to improved understanding of the etiology and mechanistic underpinnings of pragmatic impairments in ASD.